Treatment-Related Cardiotoxicity Risk Prediction for Breast Cancer Patients with a Multimodal AI-based System

Abstract
Anti-tumor therapies (e.g., anthracyclines, biologic, and immunotherapy) are the standard treatments for most
breast cancer patients, and dramatically improve survival rates. However, up to 20% of breast cancer patients
treatment with these therapies will develop some form of serious cardiovascular disease (CVD), such as heart
failure, myocarditis, or cardiac arrhythmia. Emerging data suggest CVD is now the leading non-malignant cause
of death during or after the treatment stage of breast cancer. If clinicians can accurately predict treatment-related
cardiotoxicity during the treatment stage or shortly post-treatment, they can then adjust their anti-tumor therapy
selection or prescribe interventions that reduce the risk of serious CVD. However, our preliminary data show that
clinicians face several challenges in predicting these serious events, including the unpredictable nature of
cardiotoxicity, the lack of specific clinical guidelines, and the low sensitivity of diagnostic tests. Recent advances
in artificial intelligence and machine learning (AI/ML) have shown great potential to support clinicians in making
early decisions about CVD. For example, our and other predictive AI/ML models that were trained and evaluated
on cancer patients’ historical electronic health record (EHR) data to predict the risk of a future CVD onset, have
yielded promising results. Yet, these existing AI/ML models for risk prediction have inherit limitations, as their
predictors are limited only to sparse EHR data; whereas clinicians in practice rely on additional modalities for
key signals such as patient-reported symptoms (e.g., discomfort in breathing) from non-clinical settings such as
at home, and change in anti-tumor treatment (e.g., increase in dose). To date, these signals are entirely missing
in existing risk prediction models for CVD of breast cancer patients. Our primary objectives are: to complement
EHR data with multimodal data collected using digital health technologies and to develop a better AI/ML risk
prediction model for breast cancer treatment-related cardiotoxicity based on the EHR data and the multimodal
data. In aim 1, we will recruit stakeholders, design and develop a human-centered smart system with wearable
sensors and a conversational large language model (LLM) chatbot for passive collection of multimodal data. In
aim 2, we will recruit breast cancer patients in active treatment, and will collect heart rate variability (HRV) using
wearable devices and capture the symptoms potentially related to cardiotoxicity using the LLM chatbot in the
home setting. In aim 3, we will first create a deidentified dataset with complete visits and long-term EHR history
for patients with breast cancer, corresponding chemotherapy treatments, and potential cardiotoxicity risk. Then,
we will develop early treatment-related cardiotoxicity prediction model with large-scale sparse EHRs, and fine-
tune the cardiotoxicity prediction model with additional small-scale dense signals. In aim 4, we will update the
human-centered AI system to include the dynamic cardiotoxicity risk score in the physician-facing dashboard
and evaluate the updated home-based smart system with physicians. Our findings are expected to innovate and
improve treatment-related cardiotoxicity risk prediction and facilitate clinical decision making.

Public health relevance
Project Narrative Treatment-related cardiotoxicity is a key unappreciated driver of mortality after breast cancer treatment, but there are critical gaps in early detection and treatment initiation. Risk assessment based on artificial intelligence/machine learning (AI/ML) models is vital to address treatment-related cardiotoxicity early detection, but existing predictive models have limitations and are based on potentially biased and deficient electronic health record (EHR) data. The goals of our project are to: 1) collect multimodal health data in a non-clinical setting using digital health technologies and wearable devices; 2) develop a risk prediction model of breast cancer treatment-related cardiotoxicity based on EHR data and the multimodal data; and 3) develop a human- centered AI system with a physician dashboard presenting the risk score and other key patient health metrics for clinical decision making, and evaluate the system.